Clinical Protocol and Data Management

Clinical Protocol and Data Management (CPDM)
ABSTRACT
The City of Hope Comprehensive Cancer Center (COHCCC) CPDM provides a centralized, comprehensive
infrastructure which supports the conduct of all translational and clinical research. The CPDM encompasses two
divisions: (1) Clinical Research Operations and (2) Clinical Research Informatics. The CPDM is led by Dr. Larry
Kwak, MD, PhD, Associate Director for Experimental Therapeutic and Translational Research. Clinical Research
Operations is led by Ashley Baker Lee, Senior Vice President for Research Operations and is responsible for
study activation, education and training, policy and procedure development as well as accruals, data
management and quality, and data and safety monitoring. Informatics, which includes Clinical Research
Informatics, is led by Sorena Nadaf, Senior Vice President and Chief Informatics Officer and continues to provide
support for the centralized systems which house COHCCC protocols (CTOL), clinical trials management system
(MIDAS) and case report form development (Medidata Rave).
The CPDM provides a strong foundation for high-quality clinical research by ensuring quality design of COH
initiated research, efficient study start up, accurate collection of data to meet protocol objectives, protocol
compliance and monitoring trial conduct and progress. As a centralized and integrated resource, CPDM provides
dedicated and experienced staff to support COH’s robust and growing research portfolio.